Remote, Young Adult Lay-Counselor Delivered Behavioral and Digital Intervention for Youth to Promote Vaping Cessation and Prevent Escalation of Tobacco Use

PROJECT SUMMARY/ABSTRACT
While tobacco smoking has declined dramatically among adolescents and is now almost rare, the prevalence
of electronic nicotine delivery device (ENDS, nicotine vaping) use has risen rapidly, fueled by social media
promotion, innovative product engineering, and advertising, and effectively reversing five decades of progress
in youth tobacco control. The increase in high school vaping from 2017-18 was the largest one-year increase in
any substance used over the 44 years that Monitoring the Future has tracked adolescent substance use. In
2019, 26% of U.S. high school seniors reported past month vaping, a 5% increase from 2018, with the
sharpest inflection in vaping initiation at around age 16. Most youth who initiate ENDS use have never smoked
tobacco; however, nicotine vaping is associated with subsequent initiation of tobacco smoking. This is of high
public health importance because high school aged adolescents are in the developmental period with the
highest lifetime vulnerability for drug use to progress to entrenched addictive patterns. Thus ENDS use puts
adolescents at high risk for nicotine addiction, escalation to entrenched combusted tobacco, multiple tobacco
product, and other drug addiction, in addition to negative health effects of vapor exposure. Recent surveys
indicate that over half of adolescents who vape nicotine want to quit, but there are no known effective
treatments to aid the millions of U.S. adolescents who have begun to vape nicotine to quit. There is growing
consensus that effective interventions are needed for adolescents with pre-addiction, operationalized as mild to
moderate substance use disorder, with the rationale that early interventions could prevent escalation to often
lifelong patterns of drug use. Thus, here we propose to enroll adolescents with at least once weekly vaping in
the past month, whose mild severity of use would exclude them from most cessation clinical trials. Because
vaping has become so prevalent in high schools at a time of unprecedented behavioral health workforce
shortage, effective interventions that are scalable into school and community settings are needed. We
designed QuitVaping to be a fully remote, digital and behavioral intervention, grounded in Cognitive Behavioral,
Social Cognitive and Dissonance Theory to be developmentally appropriate for mid and late adolescent
tobacco vaping cessation. QuitVaping is delivered over twelve 20-minute sessions by young adult lay
counselors. QuitVaping has high satisfaction ratings, retention, and abstinence rates in preliminary testing in
adolescents with established nicotine dependence. Here we propose to test QuitVaping to promote nicotine
vaping cessation in youth who vape as little as at least once a weekly, and thus are at risk for progression
along the spectrum of addictive disorders, with no, mild or moderate dependence on vaped nicotine, thus
meeting criteria for pre-addiction. To maximize generalizability, the trial will have few exclusion criteria for
subsyndromal psychiatric and substance use disorder (SUD) symptoms but will exclude and refer for clinical
care those with any severe SUD. To do so, we propose to enroll 300 adolescents, ages 14-18, from high
school and community settings, who are willing to try to quit vaping, into a double-blind, parallel group, intent-
to-treat trial of the effect of QuitVaping vs Enhanced Usual Care (psychoeducation, advice to quit, and referral
to a free texting-based support, This is Quitting (TIQ)) on abstinence from ENDS, other tobacco use, and other
drug use at the end of 12 weeks of treatment and 6-month follow up. Adherence and retention, well-
documented challenges in adolescent smoking cessation trials, will be incentivized and supported with the
innovative Emocha smartphone application that will deliver session reminders and collect daily vaping data.
This proposal is innovative and responsive to urgent and growing requests for tobacco vaping cessation
treatments from adolescents, their families, and schools. Positive results will define an effective, affordable,
scalable intervention that can be deployed in homes, schools, and clinical settings to combat the rapidly
resurgent epidemic of youth tobacco use.

Public health relevance
PROJECT NARRATIVE Electronic cigarettes have exploded in popularity amongst adolescents, renormalizing tobacco use in non- smoking adolescents, and increasing risk for tobacco smoking, other drug use, and direct negative health effects of vapor exposure. Amidst growing demand for adolescent vaping cessation interventions where no proven treatment exists, we have developed QuitVaping, a scalable, fully-remote, young adult lay counselor delivered intervention with digital content that is well accepted and showing promise for vaping cessation in adolescents who vape nicotine daily. This project will determine whether QuitVaping is effective for vaping cessation in mid to late adolescents who vape nicotine at least weekly.